The Relationship Between Historical Trauma, Substance Use, and Suicidal Ideation in Native Hawaiian/Pacific Islander Adults: A Mixed-Methods Approach

Project Summary/Abstract
Research targeting substance use and its comorbidities in Native Hawaiian/Pacific Islander (NHPI)
communities often focuses on youth participants or aggregates small samples of NHPIs with the data of Asian
Americans. This has created a significant gap in the field’s understanding of substance use and suicidal
ideation in this underserved population. Further, NHPI advocacy groups cite both substance use and historical
trauma as primary targets for research. Therefore, the specific aims of this project are to (1) conduct qualitative
focus groups to understand the relationships between substance use, suicidal ideation, and historical trauma in
NHPI adults and (2) conduct a subsequent quantitative analysis to develop a model of these associations. This
project is significant because we will be building the first model of substance use and suicidal ideation in
NHPI adults, a community that has been largely underserved by academic research. This project is innovative
because it will utilize a mixed-methods research design with community based participatory research
principles, including the formation of a NHPI community advisory board, to inform this model. The proposed
study will be completed over the course of two years and two studies; the first is qualitative, the second
quantitative. Study 1 will conduct 3–5 focus groups with 4–8 NHPI adults per group (n = 20–30) who will
explore the impact of historical trauma on substance use and suicidal ideation using semi-structured interviews
that will mirror traditional NHPI talking circles. Study 2 will translate the themes revealed in the qualitative
analysis from Study 1 to inform measure selection in a quantitative analysis, with the goal of testing a model of
the relationships between historical trauma, substance use, and suicidal ideation in NHPI adults (n = 120–168).
Findings will be among the first to conceptualize these relationships in NHPI adults, where research is
desperately needed. This project is aligned with NIDA’s 2022-2026 Strategic Plan as it explores the social and
contextual factors that manifest and maintain substance use behavior by exploring comorbidities and improving
the implementation of evidence-based practice for clinicians who seek to reduce substance use in NHPI
communities through the development of the model. Further, this project will provide the Principal Investigator
with the grantsmanship, networking, and methodological tools to establish a career serving the needs of NHPI
communities. The research environment at University of Rhode Island including office space, technology, and
grant support, along with excellent sponsors and consultants with expertise in relevant content areas and
mixed methodology research, provide the ideal setting and mentorship to successfully conduct the proposed
project. This project will create vital research training opportunities for the applicant’s future career as an
independent researcher working within NHPI communities to alleviate health disparities, a role which is
necessary for improved health among this population.

Public health relevance
Project Narrative Due to small sample sizes and the persistent aggregation of Asian American and Pacific Islander data, there is a significant dearth of research on substance use and suicidal ideation in Native Hawaiian/Pacific Islander adults. The proposed project will: (1) provide essential training in conducting ethical research and collaborating with this highly minoritized community and (2) use a sequential mixed-methods methodology paired with community-based participatory research to explore the relationships between substance use, suicidal ideation, and historical trauma among Native Hawaiian/Pacific Islanders. Results will fill significant gaps in the extant literature related to health disparities within this understudied community.